Shared Resource: Prevention Center

PROJECT SUMMARY: PREVENTION CENTER SHARED RESOURCE (PCSR)
The goal of the Prevention Center Shared Resource (PCSR) is to facilitate transdisciplinary, collaborative
research within the Consortium, focused on better understanding the contributions of behavior/lifestyle
modification, nutrition, physical activity, and obesity to cancer development, prognosis, and survivorship.
Centrally located at Fred Hutch (FH), the PCSR accomplishes this by providing Consortium investigators
access to well-trained staff and a full-service research facility (over 10,000 nsf) that contains a Research Clinic
(RC), Exercise Research Center (ERC), and Human Nutrition Lab (HNL). The RC is staffed with medical
personnel who can perform clinical assessments, collect biospecimens (including various biopsies), and obtain
detailed anthropometry. The ERC conducts exercise training and testing, including VO2 max, spirometry, and
indirect calorimetry. Trained exercise physiologists are available to help investigators design tailored exercise
programs and to oversee exercise sessions for study participants. The HNL provides comprehensive support
for the conduct of human feeding studies as well as the food component of behavioral and community nutrition
intervention studies. Services include study diet design, food production and delivery, meal service, data
collection, and study participant management and monitoring according to diet intake protocols. The PCSR
also provides training and certification for technical staff and serves as a support resource and training facility
for investigators, post-doctoral and clinical fellows, and students interested in exercise science and nutrition
research.
Given the increasing number of individuals in the US affected by cancer, it is of great importance to identify
causes of cancer that are preventable and ways to improve the quality of life among cancer survivors. The
long-term goal of the PCSR is to maintain itself as a unique, cutting-edge resource for the Consortium, to
facilitate advances in our knowledge of the behavioral/lifestyle, nutritional, physical activity, and obesity-related
contributors to cancer development, prognosis, and survivorship.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.